3D Printed Configurable and Themoresponsive Intracortical Electrode Array Platform

PROJECT SUMMARY:
Long-term neural recording using implantable devices has provided important discoveries that have shaped our understanding of how the neural circuitry of the brain works and, more recently, has been used experimentally to treat such disorders as paralysis that provide hope for many suffering from this disability. This promising technology has been challenging to implement reliably over long periods, limiting its use as a chronic basic science tool and threatening its widespread clinical utility. The next-generation implantable devices will need a configurable design and tissue-like material properties. Our project is focused on fundamentally changing the intracortical electrode platform available by integrating two-photon 3D printing technology with thermoresponsive and biostable electrode materials (Gallium-based liquid metal) to design scalable, configurable, and chronically reliable intracortical electrode arrays. The results will provide knowledge that will allow more rapid development of improved and next-generation electrode arrays that work better than what currently exists. The broader impact should inform improved biomedical device design in general and those intended for chronic use in contact with central nervous system tissues.

Public health relevance
PROJECT NARRATIVE: Despite the significant progress in implantable electronics for the brain, there is still a consistent demand for devices with configurable architecture and tissue-like material properties This proposal will combine high-resolution two-photon 3D printing technology with biostable and thermo-responsive electrode materials to create a scalable and customizable intracortical electrode array with tissue-like mechanical properties capable of seamless integration into the central nervous system.